Smart Aspiration Catheter Based on Fiber Optic Pressure Sensing for Mechanical Thrombectomy in Stroke

PROJECT SUMMARY/ABSTRACT
Acute ischemic stroke is a leading cause of death and disability worldwide and creates a massive
socioeconomic burden. The current standard of care of the ischemic stroke caused by large vessel occlusion
is mechanical thrombectomy. This neuro-interventional procedure delivers a catheter into the occluded artery
and applies aspiration to engage and remove the blood clot. However, during thrombectomy, the physicians
have no reliable way to judge the status of the catheter interaction with the blood clot, leading to uncertainty,
multiple attempts, and an unnecessarily high rate of complications, and poor outcomes. The goal of this study
is to provide real-time data informing the interventionalist of the catheter/clot/artery interaction during
thrombectomy for safe and effective clot removal in stroke treatment. To achieve this goal, a smart aspiration
catheter with fiber optic pressure sensors integrated near the tip will be designed, prototyped, and validated to
identify 1) a gap between the catheter tip and clot, 2) a jam of catheter with a stiff clot, 3) the collapse of an
artery, and 4) the breakage of an engaged clot. These four types of interaction have been observed to be
associated with thrombectomy failure and complications in a human cadaveric study. Three specific aims are
proposed. In Aim 1, two types of fiber optic pressure sensors with front and side sensing orientations will be
designed for catheter integration. These sensors will be fabricated and experimentally calibrated. In Aim 2, the
smart catheter with sensor locations, sensing orientations, and ranges will be designed based on a fluid-
structure interaction model that calculates the pressure distribution near the catheter tip during the
aforementioned four types of catheter-tissue interaction in mechanical thrombectomy. The catheter will be
prototyped and evaluated using an engineering bench-top phantom system. In Aim 3, the safety and efficacy
of the smart catheter will be validated in human cadaveric brain and rabbit models at Mayo Clinic. This
proposed research is innovative, because it makes the current thrombectomy system “smarter” while most
ongoing effort in thrombectomy device development focuses on a “stronger” aspiration, and because it is the
first of its kind to apply fiber optic pressure sensing to real-time thrombectomy monitoring. This project is
significant, because it enables a data-driven, informed, safe, and effective thrombectomy for stroke treatment
with potential applications in pulmonary embolism and deep vein thrombosis. This study is designed to
strengthen the research environment and support undergraduate student research at Worcester Polytechnic
Institute (WPI). The transdisciplinarity of this project is invaluable to expose students to modern research
strategy and attractive to undergraduate students. This research combines theory and practice, aligning well
with WPI undergraduate educational goal. The collaboration with Mayo Clinic, a national top medical school,
strongly strengthens the research environment and the clinical translation potential at WPI.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on enhancing the safety and efficacy of mechanical thrombectomy in ischemic stroke treatment by providing real-time in-vivo monitoring of the catheter interaction with surrounding tissues. The proposed research will contribute fundamental knowledge about the mechanism of action and failure mode in mechanical thrombectomy from the fluid and solid mechanics standpoint, as well as the fiber optic sensing design for neuro-interventional applications. The long-term goal of this research is to apply fiber optic sensing technology to create a “smart” thrombectomy system for data- driven, safer, and more effective intervention, with expanded applications from ischemic stroke to pulmonary embolism and deep vein thrombosis.